Impact of actin binding protein Coronin 1C in the pathogenesis of Parkinson's disease

Parkinson’s Disease (PD) is a progressive neurodegenerative disease and is commonly characterized by tremor,
bradykinesia, stiffness, and postural instability. PD is estimated to be prevalent in 572 individuals per 100,000
individuals over 45, with an estimated 1.2 million cases in the US by 2030. While the exact cause of PD is not
known, a multitude of factors, including environmental and genetic factors have been identified and attributed to
increase the risk of developing PD. Many genetic forms of PD have been described in the last two decades in
addition to risk genes identified through candidate gene studies and genome-wide association studies (GWAS)
and over 90 independent genome-wide significant risk signals have been described. Such genetic forms allow
for the identification of mechanisms and pathways, and they could become therapeutic targets when validated.
The most common genetic forms of PD are mutations in the LRRK2 gene. LRRK2 is a multidomain protein with
both a GTPase domain and a kinase enzymatic domain. While LRRK2-PD is thought to present with a more
homogenous clinical and neuropathological pattern due to its single genetic cause, there are still striking
differences among LRRK2-PD, which pose several critical questions: why is it that not all LRRK2 variant carriers
develop PD (reduced penetrance)? Why can the age at disease onset be quite variable even within families
(variable age at onset)? Why does the neuropathology vary between LRRK2-PD cases, even in cases with the
same allelic variant (pleomorphic pathology)?
In this project, we aim to develop a system to test genetic modifiers in the context of LRRK2-PD and we
nominated a variant in the CORO1C gene, which was recently found in the first LRRK2 GWAS study. We will
combine advanced Clustered Regularly Interspaced Short Palindromic Repeats (CRISPR) and induced
pluripotent stem cell (iPSC) technologies to edit a single point mutation and modulate gene expression of
CORO1C. This will allow us to generate an isogenic panel of human iPSC lines, in which we edited a single point
mutation and activate or inhibit CORO1C expression to probe for gain-or loss-of function phenotypes in healthy
and LRRK2 human iPSC neurons. Our aims are: Aim 1: To derive such human CRISPR engineered iPSC tools;
Aim 2: To assess to what extent CORO1C affects cellular function, and alpha-synuclein or tau expression and
post translational modifications; Aim 3: To determine to what extent CORO1C has an impact on LRRK2 function.
The outcomes will have a critical impact on defining new mechanisms related to neurodegeneration and
functionally validate CORO1C as a new disease target for PD nominated by clinical research-based genome-
wide association. This in vitro approach of up/down-regulation of genes from their endogenous loci combined
with specific disease-associated SNP gene editing and could serve as a testbed to unravel the functional
consequences of genetic risk factors as modifiers in PD and related Lewy body pathologies.

Public health relevance
The long-term goal of this research is to understand better what genetic factors influence disease risk, clinical symptoms, and penetrance of Parkinson’s disease (PD) and related Lewy body diseases. Specifically to this application, we will develop the framework and in vitro models on how to test putative genetic modifiers in the context of LRRK2 parkinsonism (LRRK2-PD). Using different CRISPR gene editing and perturbation tools, we will explore how a putative modifier, CORO1C intronic variant, can affect neurite morphology, endolysosomal and mitochondrial function, and LRRK2 function in human iPSC neuronal cultures to establish causal relationships between CORO1C and LRRK2-PD and validate CORO1C as a new disease target for PD and related Lewy body pathologies.